Developmental Brain Connectomes and Substance Use in Adolescence

PROJECT SUMMARY/ABSTRACT
Adolescence is a unique neurodevelopmental period where bottom-up limbic processes are pronounced while
top-down executive control is onboarded throughout this age range. This results in mismatch in
neurodevelopment that favors subcortical network activity, rather than top-down inhibitory control networks. It is
suggested this drives states that can outwardly appear impulsive and risk-taking, such as escalating substance
use. Specific to this relationship is the deleterious effects of nicotine use on brain structure and function.
Concerningly, nicotine and tobacco product usage are rising in prevalence rates among adolescents (i.e., during
this unique neurodevelopmental period) and onset of these substances confer higher likelihood of increased
use, development of substance use disorders, and later psychopathology. However, few studies have
investigated the impact of nicotine exposure and use escalations on structural and functional brain networks in
a prospective and longitudinal design. Let alone, utilizing advanced statistical approaches to combine structural
and functional connectome data to fully investigate large-scale and unique network signatures of nicotine and
tobacco product use. Moreover, given inherit sex differences in neurodevelopmental timing of both structural and
functional brain outcomes, it stands to reason that sex differences may exist in how nicotine impacts these
developmental trajectories. Despite this line of research, examinations of sex differences are limited and often
skewed by sample distribution. Thus, this proposal seeks to investigate these questions in a large-scale and
demographically diverse sample, prospectively, and prior to nicotine use initiation. This will be done through
secondary data analysis leveraging the landmark NIH-funded Adolescent Brain Cognitive Development (ABCD)
Study, following over 11,800 youth across 10 years. Functional and structural brain data will be utilized across
the study period (5 time points), with a myriad of other biopsychosocial measures (including other exposures of
nicotine: prenatal, secondhand, environment), in predicting network-based longitudinal trajectories (ages 9-18).
This fellowship would provide Dr. Sullivan with an exceptional opportunity to build his skills within advanced
longitudinal neuroimaging design, resting-state fMRI, diffusion tensor imaging, network-based statistics, all while
building upon his foundation in substance use. A dedicated mentorship team of ABCD Study leaders and users
of this data, with expertise in these domains, will ensure exceptional training. At the conclusion of this two-year
fellowship, Dr. Sullivan will meet his goals of developing a diverse and high-quality skill set to carry into a K08
proposal and progress to an early career faculty status as a clinical research scientist with an expertise in
substance use in neurodevelopmental contexts across cognitive, reward, and affective neurobiological domains.
In addition, he will possess technical expertise of advanced longitudinal statistics, breadth of neuroimaging
approaches, and leveraging large-scale “big data” to answer timely and impactful research questions across
these areas.

Public health relevance
PROJECT NARRATIVE Adolescent neurodevelopment consists of subcortical reactivity before top-down cortical executive control networks regulate these processes, which can result increased risky behaviors, including rising prevalence of nicotine and tobacco product usage. However, the interactive development of brain networks and nicotine use has yet to be fully investigated in a prospective, longitudinal design, let alone in a large and nationally representative cohort. This proposal seeks to utilize advanced network-based connectome analyses of structural and functional neuroimaging data across multiple time points from late childhood to late adolescence (9-18) and investigate how escalating nicotine use patterns may lead to aberrant trajectories in brain development.